Developmental Research Program

Developmental Research Program SUMMARY/ABSTRACT
The purpose of the Developmental Research Program (DRP) is to fund promising projects by investigators
whose current work may not focus exclusively on ovarian cancer, but who propose highly innovative
translational studies of ovarian cancer that could become full SPORE projects or compete successfully for
funding outside of the SPORE. The DRP provides a unique opportunity for making available significant financial
support, and for demonstrating active institutional support, through a program that is rapidly responsiveto new
ideas or initiatives. Moreover, this program is rooted in a spirit of collaboration promoted by the SPORE
investigators who have an extensive track record of bringing investigators from other disciplines into ovarian
cancer research. The strength of the DRP rests in its ability to make available financial support needed to
access all the critical expertise and resources within the entire SPORE. This will allow us to develop
collaborative, multi-investigator, multi-institutional research projects with the support of innovative, investigator-
initiated projects that have the potential to flourish into reliable and productive translational research projects
that make a path from basic and/or population research projects into research focused on human clinical
specimens/patient populations. Over the course of the past decade, the MD Anderson OvarianSPORE has
supported DRP projects from 22 investigators. Collectively, these investigators have published 470 peer-
reviewed manuscripts related to ovarian cancer. Thirteen of the recipients have received peer-reviewedfunding
in ovarian cancer as either PI, Co-PI or Co-Investigator. The investigators have received funding from three
R01s, three R21s, three CPRIT awards, two Department of Defense Awards and four OCRA awards. One
awardee in the most recently funded cycle just received support from both the Ovarian Cancer Research Alliance and
Foundation for Women’s Cancer. Additionally, three former awardees have participated in full SPORE projects
after completing a DRP project.